PRECANCEROUS GASTRIC LEASIONS--STOMACH CANCER IN CHINA

The objectives of this project are to describe and evaluate the determinants of gastric dysplasia, intestinal metaplasia and chronic atrophic gastritis, conditions thought to be precursors to stomach cancer, in a population in Shandong, China where stomach cancer rates are high. This will be accomplished by continued followup of a population of 3,400 adults age 35-64 classified by (1) gastric status determined by gastroscopy; (2) diet, tobacco consumption, medical history and other exposures obtained via interviews; and (3) measurements of nutrients and other substances in blood, urine, and gastric juice. Rates of transitions of these gastric lesions to cancer will be determined via follow-up of the study population over a 6-year period.